Characterizing Evoked Potentials of Deep Brain Stimulation for Parkinson's Disease

Deep brain stimulation (DBS) is a surgical intervention used to treat the cardinal motor symptoms of
Parkinson’s disease (PD) when medical interventions fail. While DBS for the motor symptoms of PD has been
used for decades, there are still gaps in our knowledge on the underlying mechanism of action, which, if
resolved, might enhance DBS outcomes further. One point of improvement in DBS can be found in the process
of DBS lead placement. DBS lead placement is a challenging, time-intensive procedure based on radiographic
criteria, then refined by confirming motor symptom reduction and assessing side effects intraoperatively in
awake patients. DBS lead placement may be improved using evoked potentials (EPs) as objective, surrogate
biomarkers linked to neural activity and appropriate symptom relief. EPs have potential to guide appropriate
placement of DBS leads more rapidly and accurately, possibly even in patients under anesthesia, particularly
in subthalamic nucleus (STN) implants. The use of EPs as a biomarker may reduce surgical time, improve
patient outcomes, and improve patient comfort. The goal of this proposal is to characterize the effect of
stimulation amplitude, lead location, and anesthesia on local and distant EPs to identify more reliable and
efficient methods of lead placement. This will be particularly impactful if EPs correlate with symptom relief,
removing the need for behavioral characterization and expediting awake and/or asleep DBS lead placement.
The first aim is to quantify the effect of DBS amplitude and location on local and distant EPs during
awake DBS lead placement. Experiments will occur in concert with partnering neurosurgeons and neurologists.
Local and distant EPs will be recorded simultaneously during DBS at the target of the dorsal STN and off-
target at the ventral STN. DBS stimulation trials will include sub-therapeutic, therapeutic, and supra-therapeutic
intensities. Before and during the DBS trials, I will concurrently quantify bradykinesia and tremor. Next, I will
repeat DBS trials in follow-up clinic one month later to determine the predictive value of intraoperative EP
recordings on post-op symptom treatment. The second aim will repeat these steps in patients undergoing
asleep surgery. These studies are expected to quantitatively establish the causal relationship between DBS
and EPs, and the correlative link between EPs and behavior critical for the use of EPs in the clinical setting.
This proposal will ultimately support my training as a dual-degree MD/PhD student, in preparation for a
career as an independent physician-scientist at the intersection of the bench and the bedside. The training plan
will include attending conferences, gaining further clinical experience, and further developing my scientific
reasoning skills. The training environment is well-equipped to prepare me for my future career as a physician-
scientist. My primary sponsor (PI) has a long record of mentoring trainees and is an expert in the field of DBS,
and the lab has a long record of successful collaboration with partnering physicians, several of which will also
provide direct mentoring support, to help guide my long-term clinical career.

Public health relevance
Deep Brain Stimulation (DBS) lead placement is a challenging and time-intensive procedure often requiring patients to be awake to confirm motor symptom reduction and assess side effect profile intraoperatively. Evoked potentials (EPs) hold promise as biomarkers to guide appropriate placement of DBS leads more rapidly and accurately, possibly even in patients under anesthesia. In this way, the use of EPs as a biomarker may reduce surgical time, improve patient outcomes, and improve patient comfort.